The effect of intermittent hemidiaphragm stimulation during surgery on mitochondrial function, single fiber contractile force and catabolic pathways in humans

Although mechanical ventilation (MV) is life-sustaining in patients with respiratory failure, it comes with a cost. MV dramatically reduces diaphragm contractility, induces ventilator-induced diaphragm dysfunction (VIDD) and sometimes leads to weaning failure. VIDD includes reduced mitochondrial respiration and increased oxidative stress, muscle fiber damage and decreased diaphragm force production. In animal models, intermittent diaphragm contraction during MV support attenuates VIDD. However, there are only limited data addressing this problem in humans. Here, we propose to directly test the hypothesis that intermittent electrical stimulation (ES) of the human hemidiaphragm during prolonged cardiac surgeries with MV support prevents/attenuates VIDD in the active hemidiaphragm. Mitochondrial function is central to energy metabolism and skeletal muscle function in a chronically active muscle, such as the diaphragm. Although abnormal mitochondrial function is thought to precipitate VIDD in animal models, limited data are available concerning mitochondrial contributions to VIDD in humans. Of even greater importance, there are no interventions available to attenuate these defects in humans. Here, we will test the impact of an innovative experimental treatment, intermittent electrical stimulation (ES) of the hemidiaphragm during prolonged surgeries with MV, on mitochondrial function, single fiber contractile properties and catabolic muscle pathways in human diaphragm. Using a within-subjects experimental design, muscle samples from a stimulated hemidiaphragms will be compared with samples from the unstimulated hemidiaphragm. We will investigate mitochondrial dysfunction and oxidative stress during prolonged CTS/MV, and the potential of ES to attenuate or prevent VIDD (Aim 1). Next, we will investigate the effects of ES on single fiber contractile properties and Titin integrity (Aim 2). Finally, we will study the effect of ES on proteolytic pathways (caspase, calpain and ubiquitin-proteasome) and ribosomal RNA markers of decreased protein synthesis implicated in VIDD (Aim 3). This research will provide evidence concerning the ability to improve mitochondrial function in the stimulated hemidiaphragm, and identify mechanisms contributing to human VIDD. Our long-term goal is to test various intermittent hemidiaphragm ES protocols on a larger population to determine its ability to prevent or attenuate VIDD. Data from this R01 application will advance our understanding of mechanisms giving rise to human VIDD, and may inspire new therapeutic strategies to maintain human diaphragm function during MV support.

Public health relevance
Failure to wean from MV after resolving respiratory failure affects approximately 320,000 patients in the USA per year. Thus, failure to wean from mechanical ventilation is a significant (and growing problem, and ventilator induced diaphragm dysfunction (VIDD) contributes significantly to this problem. In this study, we will determine if intraoperative electrical diaphragm stimulation attenuate early VIDD manifestations in humans.